Regulation of Energy Homeostasis by FGF21

Project Summary / Abstract
Alzheimer’s disease is a progressive neurodegenerative brain disease characterized by impairment in
cognitive function. Alzheimer’s disease is the most common cause of dementia and an estimated 5.8 million
people in the United States age 65 and older are living with Alzheimer’s dementia in 2020 (alz.org).
Accumulation of amyloid beta (Aβ), a misfolded protein, is a key pathological hallmark of Alzheimer’s
disease but drug candidates targeting Aβ pathways have yielded little success [1]. More recently, changes
in metabolism, particularly glucose metabolism, have been identified as a common feature observed in
Alzheimer’s disease [2, 3]. Notably, approximately 80% of patients with Alzheimer’s disease exhibit
impairments in glucose tolerance [4]. These observations along with other epidemiological data have led to
the postulation that Alzheimer’s disease may, in part, be a metabolic disorder [3, 5]. Fibroblast growth factor
21 (FGF21) is an endocrine hormone that corrects metabolic dysfunction and reverses diabetes and obesity
in animal models [6]. FGF21 is an important regulator of glucose homeostasis and is a potent insulin
sensitizer. Clinical trials with FGF21 mimetics have also demonstrated the efficacy of targeting this pathway
to improve metabolic profiles in humans [7]. Interestingly, recent data suggests that FGF21 administration
may also prevent neurodegeneration [8-10] and pathological deficits in animal models of Alzheimer’s
disease [11-13]. While circulating FGF21 levels are derived primarily by the liver [14], our preliminary data
reveals the unexpected discovery that FGF21 is also expressed in a very specific region of the central
nervous system. Specifically, FGF21 is expressed in the retrosplenial cortex and can signal to the
hippocampus and can regulate learning and memory. A previous study demonstrates that FGF21 is induced
from neurons in response to mitochondrial stress [9], and we hypothesize that FGF21 induction in this region
regulates metabolic processes and insulin sensitivity to prevent neurodegeneration and rescue neuronal
plasticity. Several lines of evidence suggest that during prolonged metabolic impairments, endogenous
signaling of FGF21 may be impaired leading to a “FGF21 resistant state” [15]. Importantly, administration
of pharmacological levels of FGF21 is sufficient to overcome this resistance and restore metabolic
homeostasis [16]. In this proposal, we seek to explore how FGF21 affects the metabolic functions and
insulin sensitivity and signaling in the hippocampus of normal and Alzheimer’s disease mouse model and
whether restoration of central FGF21 signaling, via pharmacological administration of FGF21 or local
induction of FGF21 via sustained adeno-associated viral delivery, is sufficient to attenuate the cognitive and
pathological deficits in a mouse model of Alzheimer’s disease. Together, these studies will provide a better
understanding of potential metabolic abnormalities during Alzheimer’s disease and may reveal a potential
therapeutic approach to treat Alzheimer’s Disease and its related dementias.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease is a degenerative brain disorder characterized by defects in memory, but is also associated with metabolic dysfunction, leading some to suggest that Alzheimer’s disease may also be a metabolic disorder. Fibroblast growth factor 21 (FGF21) is an endocrine factor that signals to the brain to maintain metabolic homeostasis, and pharmacological administration of FGF21 improves metabolic profiles in both rodents and humans with metabolic dysfunction. In this proposal, we will explore the therapeutic potential of FGF21 to attenuate the metabolic, endocrine, and pathological deficits associated with Alzheimer’s disease.